Molecular Transitions Driving AR Loss in Double Negative Prostate Cancer

PROJECT SUMMARY/ABSTRACT – PROJECT 2
Despite newer and more effective therapies, prostate cancer remains a leading cause of cancer-related deaths
among men in the United States. There is a need to better subclassify prostate cancer, particularly tumors that
develop resistance to androgen deprivation, to characterize and target resistance mechanisms, and to prioritize
treatments for individual patients. Double-negative prostate cancer (DNPC) is an increasingly recognized and
clinically important form of castration-resistant prostate cancer (CRPC) that lacks both androgen receptor and
neuroendocrine marker expression. Recent studies from our group indicate that DNPC is linked to worse clinical
outcomes compared to other CRPC molecular subtypes. Additionally, diagnosing DNPC is challenging due to
the absence of reliable biomarkers, causing delays in diagnosis and missed opportunities for timely treatment.
Thus, there is an urgent need for innovative methods to detect and track the progression of DNPC. Moreover, it
is crucial to delineate vulnerabilities of DNPC to develop effective therapies for this aggressive CRPC subtype.
In this proposal, we will test the central hypothesis that DNPC is a distinct molecular subtype of CRPC that
exhibits targetable vulnerabilities through the following specific aims: Aim 1: Assess patient-level, cell-
autonomous, and tumor microenvironmental determinants of DNPC. Aim 2: Define the lineage determinants and
vulnerabilities of AR-null prostate cancers. Aim 3: Develop approaches to detect DNPC phenotypes in patients
receiving AR-directed therapy. The completion of these studies will enhance our understanding of DNPC, lead
to the development of biomarkers for DNPC detection, and identify novel targeted therapies for DNPC.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 Our understanding double-negative prostate cancer (DNPC) an emerging treatment-resistant tumor phenotype is extremely limited. We hypothesize that DNPC is driven by unique molecular features that bypass AR activity, creating specific therapeutic vulnerabilities. In this project, we will characterize the features and clinical features of DNPC and develop diagnostic and therapeutic strategies specifically targeting DNPC. These efforts will be greatly supported by the interactions with Project 1 and Project 3 and will ultimately improve our understanding and therapeutic options for this difficult-to-treat prostate cancer subtype.